Influence of HIV infection on vaginal virome and risk of preterm birth in pregnant South African women

Pregnant women living with HIV (PWLHIV) are more likely to experience adverse birth outcomes, including
preterm birth (PTB), than pregnant women not living with HIV (PWNLHIV), thereby substantially contributing to
maternal and infant morbidity and mortality in sub-Saharan Africa (SSA). Alterations in bacteria of the vagina
vaginal have been linked to PTB but this cannot fully explain the increased risk. We found that although PWLHIV
had an increased vaginal bacterial diversity and higher prevalence of bacterial vaginosis (BV)-associated
bacteria compared to PWNLHIV, HIV infection was independently associated with PTB. Therefore, other
mechanisms must be in play. The role of vaginal viral communities, collectively referred to as “virome”, has not
been evaluated. Additionally, the mechanisms of HIV- versus ARV-induced PTB needs to be investigated so that
intervention measures can be identified to mitigate these risks.
The enteric virome appears to be altered during HIV infection. Expansion of bacteriophages, viruses that infect
bacteria, has been linked to immune cell expansion and increased inflammation in the gut and gut bacterial
diversity is mirrored in the virome. In non-pregnant WLHIV, viruses from four major viral families were found in
the upper female genital tract, but no comparison to PWNLHIV was made and the presence of bacteriophages
was not evaluated. A higher prevalence of human papillomavirus (HPV), especially of high-risk types, has been
found in WLHIV compared to WNLHIV. However, to date, limited data exist on the effect of HIV on the collective
vaginal viral community, which is likely to be altered. Likewise, few studies have investigated the relationship
between the vaginal virome and PTB. Here we hypothesise that HIV infection leads to an expanded vaginal
virome, including increased number and diversity of bacteriophages, which either directly or indirectly (through
alteration of the bacterial microbiota) is associated with a higher PTB risk in PWLHIV. As part of this proposed
project, we will leverage the infrastructure and samples, as well as rigorous and extensive data of two ongoing
cohorts of pregnant women in Cape Town, South Africa to address this hypothesis with the following Specific
Aims:
Aim 1: To assess the effect of HIV, pregnancy and antiretroviral drugs on vaginal virome diversity and
composition. Hypothesis 1: PWLHIV have an expanded vaginal virome compared to PWNLHIV
Aim 2: To evaluate vaginal bacteriophage-host interactions in PWLHIV. Hypothesis 2: Viral communities
alter the bacterial component of the vagina through predator-prey dynamics
Aim 3: To compare vaginal virome diversity and composition in women experiencing PTB versus age-
and parity-matched women with normal birth outcomes. Hypothesis 3: Expansion of the vaginal virome is
responsible for increased rates of PTB.

Public health relevance
Women living with HIV are at increased risk for preterm birth and have altered vaginal bacterial communities. Here we will test the hypothesis that HIV infection leads to an expanded vaginal virome, which either directly or indirectly (through alteration of the bacterial microbiota) is associated with a higher preterm birth risk. Understanding the interplay between HIV, antiretrovirals, vaginal viruses, bacteria and risk of preterm birth is relevant for developing novel diagnostics and interventions for improving birth outcomes among pregnant women living with HIV, and ultimately to decrease infant morbidity and mortality.